The Impact of Diffuse Mild Brain Injury on Clinical Outcomes in Children

Abstract. Pediatric mild traumatic brain injury (pmTBI) remains a large public health concern due to the number
of youths affected each year and the risk for permanently altered neurodevelopmental trajectories. Emerging
evidence from our ongoing R01 project and other independent studies suggests a potential mismatch between
symptomatic (self-reported post-concussive symptom load; PCS) and physiological recovery as indexed by
advanced imaging biomarkers. This exponentially increases the risk for a cumulative and potentially super-
additive second injury if premature decisions are made about return to activity. The proposed renewal application
builds upon a very successful R01 program (29 publications, over-recruitment [N=566 unique participants] during
COVID-19 pandemic, high [>80%] retention rates) that demonstrated diffuse microstructural and vascular injuries
that persisted up to 4 months post-injury. The proposed renewal further elucidates the mechanisms underlying
these diffuse axonal and vascular injuries, including altered myelin volume fractions, neuroinflammation
(quantified through myo-inositol and the anti-oxidant glutathione in cerebro), arterial transit times, as well as the
balance between excitatory (glutamate and glutamine) and inhibitory (γ-Aminobutyric acid; GABA)
neurotransmission that is critical for the maintenance of neuronal homeostasis. These imaging markers will be
complimented by traditional (e.g., neurofilament light [NFL], glial fibrillary acid protein [GFAP]) and novel blood-
based biomarkers of blood-brain barrier breach and endothelial damage. Our new preliminary data provides
evidence that NFL remains elevated up to 4 months post-injury and is associated with white and grey matter
abnormalities on advanced imaging, with initial feasibility studies established for all other novel imaging and
blood-based biomarkers. To achieve our renewal objectives, 178 pmTBI (ages 13-18) and 132 matched (age,
sex and social economic status) healthy controls (HC) will be enrolled across acute (1-48 hours post-injury; blood
and minimal clinical assessments); sub-acute (SA: 3-10 days; full clinical, imaging and blood collection
assessments) and early chronic (EC: ~4 months; full clinical, imaging and blood collection assessments) visits.
Patients and HC, as well as their primary caregivers, are assessed with a comprehensive Common Data
Elements clinical battery to characterize cognitive, physical and emotional sequelae of concussion. Our
published data demonstrate that equivalent assessments of clinical and biomarker data in HC are necessary to
disambiguate trauma effects from sex and age-related typical neurodevelopment, which occurs even within a 4-
month assessment window and is unique to pediatric populations (i.e., cannot be inferred from adults).

Public health relevance
Narrative: Pediatric mild traumatic brain injury (pmTBI) is a common neurological disorder that potentially alters the health and neurodevelopmental trajectories of millions of children worldwide. Approximately 20-35% of patients with pmTBI experience long-term (>3 months post-injury) physical, emotional, academic, and social consequences from their injury. Importantly, the mechanisms underlying diffuse injuries in pmTBI and the physiological recovery times remain largely unknown. Emerging evidence suggests that advanced imaging and blood-based biomarkers remain altered months post-injury. The current application directly addresses this major public health concern through the collection of innovative biomarker and clinical data in a large sample of pmTBI (N=178) during acute (within 48 hours), sub-acute (3-10 days) and more chronic (4 months) post-injury phases. An equally powered cohort of healthy controls (N=132) are included so that traumatic injuries can be disambiguated from typical neurodevelopment (i.e., sex and age-dependent effects).